Measurement and Analytics Core

ABSTRACT
The Measurement and Analysis (MA) Core will guide implementation and analysis of neurodevelopmental
assessments by supporting training, providing quality assurance and validity checks and statistical analysis and
expertise for all of the Projects in the proposed Program. An advisory team of experts in pediatrics and
neuropsychology and expertise in adaptation and implementation of neurodevelopmental assessments in sub-
Saharan Africa will be convened annually to guide study design, and data analysis and interpretation. Efficiency
of the Program is gained through use of a common MA Core with faculty and staff with many years of research
background in pediatrics, HIV, neurodevelopmental assessments and statistical methodology and analysis.